ACHIEVE Community Engagement Core

ABSTRACT
The overarching goal of the ACHIEVE GREATER Community Engagement Core (CEC) is to provide training
and infrastructure to establish community-academic partnerships and ensure meaningful community
engagement across the continuum of cardiovascular health equity CEnR conducted through the primary and
pilot projects. The specific aims are to 1) establish community-academic partnerships to ensure community
engagement in all aspects of cardiovascular health equity community engaged research (CEnR), 2) increase
community stakeholder and researcher capacity for cardiovascular health equity CEnR, and 3) provide
infrastructure to facilitate community stakeholder engagement in development, implementation, and
dissemination of cardiovascular health equity CEnR. The CEC will provide implicit bias training to all study
investigators, community stakeholders, and community health workers. We will establish a Community Review
Board to ensure community informed consent for all primary and pilot projects. We will collaborate with the
Implementation Science Team to engage community stakeholders in refinement of the PAL2 intervention and
provide assistance with recruitment and retention should projects fall below projections. The CEC will conduct
focus groups in Detroit and Cleveland to identify community cardiovascular health equity priority areas that will
shape funding themes for the pilot projects and ensure they are locally relevant and meaningful. We will
establish Cardiovascular Health Equity Action Councils (CHEAC) in Detroit and Cleveland and engage
community members in a formal research capacity building curriculum so they can effectively partner with
academic researchers on cardiovascular health equity community engaged research. The CEC will partner
with the Investigator Development core to support community-academic partnership on all pilot projects. We
will provide early-stage investigators(ESI) with formal CEnR training to build their capacity for partnering with
community members on research to address cardiovascular health equity. Each cohort of ESIs and CHEAC
members will complete our Community-Academic Partnership Study Design, Implementation, and
Dissemination toolkit to guide community engagement in pilot projects. The CEC will assist with dissemination
efforts by hosting annual research symposia and providing additional support for engaging community
members in writing abstracts, preparing and delivering presentations on study outcomes. The CEC Core will
be co-directed by Dr. Elizabeth Towner and Dr. Rhonda Dailey (both WSU); Parada Jordan (WSU) will be lead
community partner engagement and Dr. Khendi White-Solaru will be the site lead at UH/CWRU. We will track
and monitor all CEC and dissemination activities, measure knowledge and skills developed from our CEnR
capacity building efforts, and evaluate community-academic partnership formation. Collectively, CEC activities
and resources will provide a sustainable model for and a new generation of community members and
researchers to conduct highly impactful cardiovascular health equity CEnR.